SUCCEED Cancer Research Education Program (CREP)

CANCER RESEARCH EDUCATION PROGRAM: SUMMARY
Effectively addressing cancer health disparities requires a comprehensive, multidisciplinary diverse workforce to
address multi-level and complex health inequities, which are evident in the continuing disproportionate cancer
incidence and mortality rates of underrepresented minorities. To fully understand and address the most critical
factors effecting cancer health disparities, it is necessary to continuously enhance the design, approach,
implementation, dissemination, and practice of cancer health disparities research. Likewise, it is fundamental to
establish a sustainable infrastructure that will facilitate the didactic training and inclusion of more
underrepresented minority (URM) investigators and students in cancer health disparities research. Virginia State
University (VSU) and Virginia Commonwealth University (VCU) Massey Cancer Center (MCC) have established
a collaborative Cancer Research Education Program (VSU-MCC CREP) to maximize existing institutional
resources and to build an infrastructure that will increase the capacity of faculty and students to pursue and
facilitate cancer health disparities research and enhance VSU’s ability to lead in education, community
engagement, and research in cancer health disparities in Virginia.
The overall goal of the VSU-MCC CREP partnership is to pilot test cancer health disparities training and
education programs and to use the preliminary data to not only advocate for the institutionalization of these
programs but also to inform the development of a pipeline for VSU URM faculty to successfully compete for NIH
funding (K awards, R01s). The long-term goal is to develop a sustainable education and training program that
will improve the impact and scope of research discoveries and translation by increasing the number of
underrepresented minority investigators and students who can significantly inform, influence, and conduct cancer
health disparities research. Our approach is threefold: 1) develop the research capacity and capital of developing
faculty at VSU to conduct cancer disparities research; 2) increase the number of diverse students at both
institutions interested in cancer health disparities research and participating in cancer research education
experiences; and 3) increase the number of investigators at both institutions conducting cancer research.
The SUCCEED CREP will provide a set of unique and sustainable training experiences aimed at increasing the
capacity of a local historically black college to take the lead in education, community engagement, and research
in cancer-related health disparities. The organizing theme of the educational and training experiences for faculty
and students is to build the knowledge, skills, partnerships, and capacity for multidisciplinary approaches to
identify and reduce local cancer-related health disparities and their determinants.

Public health relevance
CANCER RESEARCH EDUCATION PROGRAM: NARRATIVE It is fundamental to establish a sustainable infrastructure that will facilitate the training and inclusion of more underrepresented minority faculty researchers and students in cancer health disparities research. Virginia State University (VSU) and Virginia Commonwealth University (VCU) Massey Cancer Center (MCC) have established a collaborative Cancer Research Education Program (VSU-MCC CREP) to maximize existing institutional resources and to build an infrastructure that will increase the capacity of faculty and students to pursue and facilitate cancer health disparities research and enhance VSU’s ability to lead in education, community engagement, and research in cancer health disparities in Virginia.